Biomarkers for Peripheral Circadian Clocks in Humans

PROJECT SUMMARY/ABSTRACT
Circadian clocks are present in most tissues of the body with importance for optimal physiological function and
behavior. Misalignment or disruption of peripheral circadian clocks contribute to disease and thus represent
promising novel treatment targets to improve health. The overall goal of this proposal is to improve our
understanding of peripheral circadian rhythms in humans. We will conduct a seven-weeklong
randomized, crossover, mechanistic clinical trial to 1) test zeitgebers (time cues) for peripheral circadian
rhythms, and 2) identify novel biomarkers for peripheral rhythms and explore zeitgebers for those rhythm in
humans. Preliminary data from our human circadian basic and clinical trial research set the stage for this
proposal. This mechanistic clinical trial effort is a first step to inform future development of novel circadian
based treatments for aligning peripheral clocks and for developing novel circadian biomarkers that will
advance our scientific understanding of circadian rhythms. Our overall goal and aims support the NIH
Precision Medicine Initiative and the NIH Sleep Research Strategic Plan.

Public health relevance
PROJECT NARRATIVE Circadian clocks are present in most tissues of the body with importance for optimal physiological function and behavior. This project will utilize rigorous circadian approaches to systematically test novel hypotheses about the regulation of known biomarkers of peripheral circadian rhythms in humans, and for discovery of new biomarkers of peripheral rhythms in humans. We anticipate our findings will be the first step in developing novel circadian based treatments for aligning peripheral clocks and for developing novel circadian biomarkers that will advance our scientific understanding of circadian rhythms.